SECURITY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Security functions at the Center are now performed by P.O.S.T. Certified police officers from the Tulane University Health Sciences Police Department. Officers are on-site 24 hours a day to respond to incidents, conduct routine patrols, provide after-hours escorts and liaise with local law enforcement agencies.